EARLY LIFE CONDITIONS, MORTALITY, AND LONGEVITY

Recent work in demography and epidemiology has emphasized the importance of early life experiences for mortality and longevity. Research in this area has been hampered by a lack of data at the individual level covering a sufficiently long time to measure both early experiences and mortality in later life. This project will use population register data from a Belgian village covering most of the nineteenth century to examine the effects of community, household, and individual-level measures of food scarcity and disease exposure in early childhood on mortality in adult ages.